Washington University ACCERT center

Project Summary (Abstract)
Goal: The overall goal of the WashU ACCERT is to advance cancer control equity through community -
engaged multilevel research interventions that address the impact of social determinants of health on adverse
cancer control outcomes.
Aims: The specific aims of the Center are to: (1) Bring innovation to cancer control equity research through
community-academic partnerships in using multilevel research methods and measures to develop
transformative solutions; (2) Assemble and engage an exceptional, diverse team of cancer health equity
investigators and build capacity among academic and community partners; (3) Organize and integrate Center
components in a manner that facilitates new thinking about health equity through transdisciplinary, team
science; (4) Develop a research methods, measures and data management shared resource (RMMDM core)
to support the implementation and dissemination of scientifically rigorous internal and cross center projects; (5)
Identify opportunities and develop plans to effectively address social determinates of health and reduce cancer
disparities
Strategy: WashU-ACCERT will build on a long record of community engaged research to reduce cancer
disparities and sustain mechanisms for community input of responsive research. This will be accomplished by
engaging investigators from different disciplines and investing in the development of community partners and
early-stage investigators. We will build on expertise in community-engaged research, issemination science,
and social determinants of health (SDOH) to deliver responsive products and use ongoing measures of
community engagement to monitor and adjust our processes. By continuously engaging community partners,
we will bring meaningful relief through improvements in care, build trust in the research enterprise, and
accelerate the elimination of cancer disparities.
Innovation and impact: Our proposed Center will be particularly innovative and have widespread impact by
advancing a network of cancer control equity researchers, building intellectual capital, and enhancing the
capacity for health equity in cancer prevention and control. WashU-ACCERT has distinctive features that build
on a sustained focus on cancer disparities and apply strategies to build multilevel interventions that are
responsive to community needs. These features include a uniquely diverse team as part of our Community
Responsive Research Program (CRRP), engagement and development of community partners and early-stage
investigators, strategic dissemination of products to benefit communities, and a focused strategy for collective
integration of projects and cores across ACCERT centers. This Center will ultimately advance cancer control
equity and promote capacity building among community partners.

Public health relevance
Overall Project Narrative The overarching goal of the Washington University Advancing Cancer Control Equity Research through Transformative Solutions Center (WashU-ACCERT) is to advance cancer control equity in the St. Louis region through community engaged multilevel research interventions that address the impact of social determinants of health on adverse cancer control outcomes. Our innovative strategies to promote community partnerships and implement responsive research will position WashU-ACCERT to meaningfully engage with the local communities and implement interventions that will build capacity among scholars and community partners, and benefit our communities, health systems, providers, and people at greater risk of cancer.